COMPARISON OF NONINVASIVE METHODOLOGY OF DEBRISOQUIN HYDROXYLASE

This protocol will evaluate the role of dextromethorphan beyond its usual applications as a classic marker of CYP2D6 phenotype (i.e., a categorical classification of extensive or rapid metabolizer) to a more functional role in the individualization of drug dosages by using the urinary dextromethorphan metabolic ratio as a continuous response variable quantitatively related to CYP2D6 enzyme activity.